Deciphering the cellular roles of LIS1 in the mature nervous system

SUMMARY
LIS1 mutations can have major pathological effects on human brain development, but we have
only a minimal understanding of the postdevelopmental roles of LIS1. LIS1 regulates dynein, a
molecular motor that is vitally important for distributing organelles to specific regions in the cell.
Neurons in the mature nervous system have extremely long connections called axons that place
huge demands on transport motors like dynein. LIS1 depletion in adult mice has severe
consequences - mice rapidly develop neurological problems followed by death. We suspect that
these severe responses are caused by LIS1 loss in sensorimotor and cardiorespiratory circuits.
There was no detectable cell loss or nerve degeneration so we think the problems arise at the
level of the synapses, specialized structures that are critical for normal circuits. In Aim 1 we will
determine the molecular and cellular changes correlated with the pathological responses,
focusing on dynein motors, synapses, and mitochondria, an important dynein cargo. In Aim 2
we propose to deplete LIS1 specifically from neurons (Aim 2A) and a type of glial cell called an
astrocyte (Aim 2B). Both cell types express high levels of LIS1, and both contribute to normal
synaptic function. We will be able to determine if either are the cellular source of the severe
symptoms in the earlier mouse model, or if there are cell type specific symptoms. LIS1 has a
known role in axon transport but its function in mature astrocytes has been overlooked in the
field. This work will bring new insight into functions of LIS1 in the adult brain.

Public health relevance
PROJECT NARRATIVE Reduced LIS1 levels in humans cause a devastating developmental brain disorder called lissencephaly (smooth brain). LIS1 protein remains elevated in the adult mouse brain. Depletion of LIS1 in adult mice causes sensorimotor defects and is rapidly lethal. Here we propose experiments to understand the molecular and cellular changes caused by LIS1 depletion in adult mice.